Functional profiling of germline SDH variants associated with cancer susceptibility

Objectives: Loss-of-function (LOF) mutations in SDHA or SDHB result in SDH-deficiency and
increase the lifetime risk for developing a number of cancers, including GI stromal tumors,
paraganglioma, pheochromocytoma, renal cell carcinoma, and breast cancer. In most cases,
tumors with these mutations arise in the setting of a heterozygous germline mutation, which is
heritable. In patients with a known pathogenic SDHA or B mutation, genetic counseling (to screen
other family members) and enhanced cancer screening procedures are indicated. When SDH-
deficient tumors are detected at early stages, they are often curable. Nonetheless, we currently
do not have the ability to identify patients at risk and screen them appropriately. The main
limitation is our lack of knowledge of the functional consequences of various SDHA or B
mutations; only SDHA or B variants that cause LOF lead to cancer. Germline variants of SDHA
and SDHB are relatively common (1.5% of population), however most are currently classified as
variants of unknown significance (VUS).
Plan: This proposal will generate novel models for functionally testing SDHA and SDHB VUS
seen in the population, including generating human model cell lines and utilizing a deep
mutational scanning approach. Human models, which can provide strong evidence to be used for
clinical classification of variants will be generated and validated for testing individual variants. In
addition, we have established a yeast model that allows functional screening of thousands of
SDHA/B mutations in the yeast homolog genes (ySdh1 and ySdh2, respectively). Using this yeast
model coupled with saturation mutagenesis, functional screening and deep sequencing, the
functional consequences of all SDHA and SDHB missense mutations will be profiled.
Methods: To fill the current void of SDH-deficient cell lines, we will use CRISPR-Cas9 to generate
SDHA- and SDHB-knockout cell lines and validate them to ensure their power for determining
clinical classifications for SDHA and SDHB VUS reported in human tumors (Aim 1). To address
the large number of SDHA and SDHB variants seen in the population, we will create libraries of
all possible ySdh1, (Aim 2) and ySdh2 (Aim 3) amino-acid variants by saturation mutagenesis
and transform these libraries into yeast models deficient in the relevant endogenous yeast protein
(e.g. mutant ySdh1 expressed in ySdh1-deleted yeast). We will select against SDHA/B LOF
variants by growing the libraries under conditions requiring fully functional SDH (glycerol media).
Following deep sequencing, depletion analysis will be performed. Functional interpretations
(functionally normal or LOF) will be made for each variant by comparing calculated effect scores
with those of nonsense/ synonymous controls.
Clinical Relevance: The care of veterans with cancer represents a significant portion of the
overall Veterans Affairs Health Care budget. It is estimated that more than 300,000 US veterans
harbor an SDHA or SDHB germline mutation. Our best chance of a cancer cure lies in early
detection in patients with SDH-deficient tumors, thus the critical medical need lies in classifying
SDHA and SDHB genetic variants to enable identification and subsequent screening of at-risk
patients. Identifying which US Veterans are at risk of developing an SDH-deficient cancer will
allow focused and potentially life-saving genetic counseling and enhanced cancer screening
procedures. The results from our study will also be relevant to non-veteran populations, including
family members of Veterans with pathogenic germline SDHA or SDHB mutations.

Public health relevance
Inherited DNA mutations in the SDHA or SDHB genes can cause defects in the essential metabolic enzyme, succinate dehydrogenase (SDH) and are common in the general population (greater than 1.5% of individuals). Some of these mutations have no medical consequence, but others increase the risk of developing cancer and this risk can also be passed on to children. Individuals who have inherited harmful SDH mutations should undergo screening tests to detect any cancer at an early, curable stage. Genetic counseling and DNA testing should be done for family members of individuals who inherited a harmful mutation. Of the many thousand SDH mutations already discovered from DNA testing, less than 50 have been definitively categorized as harmful or having no medical consequences. We will test SDHA or SDHB mutations to determine which increase the risk of cancer. These results will inform the counseling and medical care of the more than 300,000 US Veterans estimated to have inherited an SDHA or SDHB gene mutation.